Advanced Tissue Engineered Models of Human Cartilage for Studying Joint Disease

PROJECT SUMMARY / ABSTRACT
Disease and trauma of articular cartilage are highly debilitating to the quality of life, as damaged cartilage has a
very limited ability for self-repair. The management of articular cartilage defects continues to be a prevalent and
challenging problem with limited treatment options, in part due to the lack of high-fidelity models that would
advance our understanding of disease/injury progression and enable testing of novel therapeutics. Rodents are
commonly used to study joint disease and development, yet they fail to recapitulate key aspects of human
cartilage anatomy and biology, in particular the intricate zonal organization of human cartilage. While engineered
in vitro models can be biologically faithful, they generally lack the complexity offered by in vivo models, including
the interactions with other tissues. To address this gap, I propose to engineer zonally organized human cartilage
in vitro by applying the appropriate spatiotemporal gradients of TGF-β signaling (Aim 1), while concurrently
including living subchondral bone for enhanced osteochondral interactions (Aim 2). I seek to demonstrate the
utility of this human cartilage model for studying joint disease using a monogenic connective tissue disorder,
Marfan syndrome (MFS), in which fibrillin defects affect TGF-β bioavailability and musculoskeletal development
(Aim 3). I hypothesize that the precise regulation of TGF-β signaling and the inclusion of a subchondral bone
substrate will generate native-like human articular cartilage with zonal organization and cartilage-bone
interactions, which can be used to model diseases such as MFS. Optogenetics presents a strategy by which we
can control TGF-β signaling by light with unprecedented precision. At the osteochondral junction, biochemical
and biomechanical interactions mediate cartilage health and disease, yet most established cartilage models fail
to incorporate bone due to the complexity of supporting both tissue types. Our lab has designed perfusion
bioreactors which can provide separate physical and chemical cues to each tissue type to overcome this
challenge. Using MFS patient-derived hiPSCs, the advanced engineered cartilage model will be used to
recapitulate functional and structural features of disease, benchmarked to clinical data and compared to data
from existing in vitro models of chondrogenic micromass cultures. The proposed work will establish a novel
method for cartilage tissue engineering and provide an advanced human tissue model for studying joint diseases.

Public health relevance
PROJECT NARRATIVE The management of articular cartilage defects continues to be a prevalent and challenging problem with limited treatment options, in part due to a lack of high-fidelity models for understanding disease progression and testing novel therapeutics. Rodent models fail to recapitulate key aspects of human joint anatomy and biology, in particular the intricate zonal organization of human cartilage, while engineered in vitro models lack the complexity offered by in vivo models, such as the effects of tissue architecture and interactions with other tissues. This proposal aims to establish an advanced tissue engineered model of human cartilage with native-like zonal organization and cartilage-bone interactions for use in studying joint disease.